Investigating Career & Research Experience Access Through Evidence (iCREATE)

Project Summary/Abstract
There is an urgent need to increase the numbers and diversity of prepared graduates joining the biomedical
workforce through systematic and impactful evidence-based approaches that follow scientific practices. Florida
International University's Project iCREATE (investigating Career & Research Experience Access Through
Evidence) will address the lack of diversity in biomedical careers by designing, implementing and testing
innovative interventions; as well as investigating the effect of high-impact practices (e.g., different research
experience formats and career development opportunities) on students' career goals, career strategies, and key
student career intent and action outcomes. FIU is an urban Hispanic-serving research-intensive (R1) public
institution with over 58,000 students, 80% of which are from groups that are underrepresented in the biomedical
workforce. iCREATE centers on generating evidence for two scalable interventions that will leverage FIU's
extensive expertise in student success, diversity, equity, and inclusion and focus on programming that transforms
students' access to biomedical research experiences and career awareness and preparation. iCREATE aims to
1) develop and implement the following interventions: Careers+, a workshop for students focused on career
development strategies and biomedical career awareness, and CURE+ which expands a one semester CURE
into a two-semester advanced course-based research experience; 2) evaluate the effectiveness of the proposed
interventions and current research experiences available to select students at our institution; and 3) perform a
qualitative longitudinal study of undergraduates’ development of career goals and strategies and the impact of
research experiences and career development opportunities on student career goal trajectories. iCREATE will
advance our understanding of best-practices in preparing a diverse biomedical workforce by 1) developing and
testing evidence-based programs, thus, laying the groundwork for implementing similar efforts in life science
curricula to increase minority representation in the biomedical workforce; 2) conducting comparative analyses
across research experience formats, and across student demographics, to directly compare the impact of various
experiences on student outcomes; 3) focusing on the impact of research experiences and career development
opportunities on students from underrepresented backgrounds, an area that is significantly understudied, and 4)
following students longitudinally to comprehensively understand how students develop career strategies and
factors that trigger the intent and actions to pursue a career in biomedical research.

Public health relevance
Project Narrative Project iCREATE (investigating Career & Research Experience Access Through Evidence) will address the lack of diversity in biomedical careers by designing, implementing, and testing, two scalable and innovative interventions; as well as investigating the effect of various research and career development experiences on students' career goals, career strategies, and key student career intent and action outcomes. The desired outcome is to enhance the evidence base for effective interventions and contribute to the growing knowledge on elements that impact underrepresented minority students' intent and preparation to pursue biomedical research careers.